Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The Administrative Core will provide the infrastructure required to ensure efficient coordination, integration,
planning, and evaluation of all agent discovery activities associated with the proposed CAP-IT Center. The Core
provides an integrated multidisciplinary framework for scientific collaboration among the participating members
and Shared Resources at FCCC. To facilitate productivity, the Administrative Core will provide fiscal
management and clerical support, as well as ensure scientific rigor, data reproducibility, attention to important
biological variables, transparency, and consistent communication. Importantly, the Administrative Core will serve
as a liaison with the NCI and other Specialized CAP-IT Centers, and leverage the support of the Informatics
Core to effectively engage with the Data and Resource Coordinating Center. Active participation of CAP-IT
members in meetings, workshops and activities of the CAP-IT Network will be coordinated through the
Administrative Core. These activities will be accomplished according to four specific aims to: 1) Maintain an
effective framework of well-integrated multidisciplinary research activities by applying strong communication and
organizational skills, and frequently monitoring research progress; 2) Promote trans-Network collaborations by
coordinating and participating in CAP-IT Network meetings, and organizing inter-programmatic seminars and
workshops; 3) Engage early-stage investigators in precision cancer prevention – interception research and
disseminate findings and capabilities to the scientific community; and 4) Evaluate the progress of the proposed
CAP-IT Center using standard deliverables and defined metrics and milestones of success. The Leadership
Team, comprised of accomplished investigators with expertise in hereditary cancer syndromes, target validation,
agent screening, in vivo efficacy testing, and informatics, will provide oversight of all aspects of the research
projects, and make informed decisions at critical junctures of the discovery pipeline. In close consultation with
the NCI, the FCCC CAP-IT will leverage its unique resources and technical expertise to fuel the discovery of
agents for cancer prevention and interception within the CAP-IT Network and beyond.